Circumventing Barriers to Effective Oncolytic Virotherapy of Malignant Gliomas

OVERALL PROJECT SUMMARY
Glioblastoma (GBM) and recurrent GBM (rGBM) is arguably one of the most fatal of cancers: it remains
impervious to treatment with the current standard of care (SOC) therapies and numerous clinical trials (including
immunotherapy) have failed to meet end points for FDA approval. This makes GBM/rGBM an unmet medical
need. The unresolved problem we are trying to solve is that the rGBM tumor microenvironment (TME) is
highly immunosuppressive. To revert this immunosuppression, we and others have been utilizing direct intra-
tumoral administration of oncolytic viruses (OVs), based on herpes simplex virus type 1 (HSV1). During the
current funding cycle (2018-2023), the Principal Investigators of this P01 have contributed several discoveries
both in preclinical models of GBM and in a 50 subject phase 1 clinical trial of recurrent GBM (rGBM). Major
findings relate to how human subject rGBMs change in response to oHSV (Project 2/ Chiocca), how Notch
signaling of myeloid cells in the GBM TME impedes oHSV function (Project 3/Kaur) and how to further immune-
stimulate oHSVs by “arming” with immune-stimulatory genes (Project 1/Glorioso and Project 4/Caligiuri).
Lessons learned informs the overall hypothesis for this P01: oHSVs induce a rapid and persistently inflamed
rGBM microenvironment, correlating with efficacy in human subjects and informing further therapeutic
exploitation by arming oHSVs with additional immunostimulatory genes. To test this overall hypothesis,
the four Projects will address the following overall aims: Overall Aim 1 – Validate the findings that improved
survival for human subjects treated with oHSV correlates with rGBM and peripheral blood biologic
transcriptomic and proteomic signatures (Projects 2, 3 and 4); and Overall Aim 2- Engineer and
preclinically test the “next-generation” oHSVs “armed” with selected immune-activating genes, focusing
on clinical translation for a new phase 1 trial (Projects 1, 3, and 4) To support the efforts of these 4
Projects, we will continue to utilize the services of the oHSV Production Core (Core 1/ Goins), of the GBM
Biorepository Core (Core 2/Ligon) and of the Biostatistics and Bioinformatics Core (Core 3/Mo & Zhang). The
proposed timeline for the successful completion of the overall aims is 5 years. The principal investigators of this
P01 espouse the principle of “from the lab to the clinic and back to the lab”, where the lessons from our treated
patients can be applied to build more efficacious therapies for this fatal cancer. The potential impact of this
research is that we are proposing to not only test preclinically and clinically potentially impactful oncolytic
immunotherapies for an incurable cancer, but we have shown commitment to analyze the biologic and
immunologic effects in treated human subjects, so that we can iteratively learn possible pitfalls and devise
solutions for patients with GBM.

Public health relevance
OVERALL PROJECT NARRATIVE Glioblastoma (GBM) remains a fatal brain cancer with little progress in therapy. We aim to improve immunotherapy against this cancer by exploiting the capacity of oncolytic viruses (OVs) to rapidly change the microenvironment of the tumor from one that is profoundly immunosuppressive to one that is more immune- activated. We have generated novel OVs and have tested one in a first in human clinical trial over the last funding cycle. Data from this trial is now informing the next steps in improving OV immunotherapy: we propose clinical trial scientific correlate analyses that will lead to improved versions of OVs for clinical trials, subscribing to the concept from the “lab bench to the clinic and back to the lab bench”. The ultimate impact from our findings will result in improved patient survival outcomes.